Discovery and Mechanism of Novel General Anesthetics Targeting GABAA Receptors

Summary
GABAA receptors are pentameric ligand-gated ion channels that mediate most fast inhibitory
neurotransmission in the brain. These receptors are essential in the regulation of excitatory signals and their
dysfunction can lead to neurological disorders and mental illnesses. Their crucial roles in human health have
made GABAA receptors popular targets for a variety of drugs and therapeutics such as general anesthetics.
The most widely used intravenous (IV) general anesthetic is propofol, which acts as a positive allosteric
modulator (PAM) of GABAA receptors. In patients with risks of cardiovascular or respiratory depression, another
PAM called etomidate is often used instead. Although these IV general anesthetics work well, they often cause
adverse drug reactions such as airway obstruction and vasodilation induced hypothermia. These adverse
reactions can be resolved in the operating room through intubation and patient pre-warming, respectively. Such
interventions are inefficient and not practical outside the operating room, for example, in emergency conditions.
Therefore, this project aims to discover and characterize novel general anesthetics that are not limited to use in
controlled operating room environments. Specifically, I aim to discover GABAA receptor modulators through
functional studies, structurally characterize GABAA receptor modulator binding sites, and interrogate
mechanisms of potentiation. My proposed functional studies will utilize electrophysiology and leverage drug
leads identified through screens performed by collaborators. Concurrently, I aim to determine high resolution
structures of GABAA receptors bound to allosteric modulators via single particle cryo-EM. Once modulator
binding sites are identified, I plan to define mechanisms of potentiation with functional studies. This work will
directly result in modulators with novel mechanisms of general anesthesia that could potentially improve the
current anesthetic administration and monitoring protocols. Furthermore, this work will enhance our knowledge
of GABAA receptor pharmacology and provide a framework for future drug discovery pipelines.

Public health relevance
Project Narrative GABAA receptors play crucial roles in human health by regulating neurotransmission, which makes them attractive targets for numerous drugs and therapeutics such as general anesthetics. While these therapeutics are usually effective, they can cause side effects that limit their field utility. This project aims to address this problem while also enhancing our understanding of GABAA receptor pharmacology through the discovery and structural characterization of novel general anesthetics that act through GABAA receptor modulation.